Novel Signaling Pathways Underlying Skeletal Muscle Atrophy

PROJECT SUMMARY / ABSTRACT
Skeletal muscle atrophy diminishes the health and quality of life of tens of millions of people. Causes of
muscle atrophy include aging, muscle disuse, malnutrition, critical illness, certain medications, and a wide
range of chronic illnesses including cancer, heart failure, COPD, diabetes, renal failure, cirrhosis, rheumatoid
arthritis, and HIV/AIDS. Effects of muscle atrophy include weakness, impaired activity, falls, prolonged
hospitalization, delayed rehabilitation, loss of independent living, and increased mortality. Importantly, despite
its prevalence and severity, skeletal muscle atrophy lacks a specific and effective pharmacologic therapy and
thus represents an enormous unmet medical need. Development of pharmacologic interventions for muscle
atrophy has been hindered by the fact that the molecular basis of muscle atrophy is highly complex, poorly
understood, and still largely unexplored. The research proposed here would help to address this issue by
investigating a stress-inducible molecular signaling pathway in skeletal muscle fibers that appears to be
necessary and sufficient for muscle atrophy during at least 3 clinically important scenarios (aging,
immobilization and fasting). We originally discovered this pathway through unbiased systems-based
strategies, which have, to date, identified several critical pathway components, including Gadd45a (the
pathway's centerpiece), ATF4 (an essential upstream regulator of the Gadd45a gene), and MEKK4 (an
important downstream mediator of the Gadd45a protein). Our proposed studies will build upon these important
initial findings to more deeply investigate and understand the upstream mechanisms that control Gadd45a
expression (Aim 1), the pathophysiological consequences of Gadd45a expression in muscle (Aim 2), and the
downstream mechanism(s) by which Gadd45a promotes muscle atrophy (Aim 3). These studies should
significantly advance our understanding of how muscle atrophy occurs at the molecular level and facilitate
achievement of several longer-term goals, the most important being the development of new therapeutic
approaches for reducing muscle weakness and atrophy in people who are ill, injured and/or aged.

Public health relevance
PROJECT NARRATIVE Muscle wasting is a very common and serious problem, but it is poorly understood and lacks a medical therapy. Our research is focused on a protein called Gadd45a, which appears to act as a switch that turns on muscle wasting. By studying how Gadd45a is controlled and how Gadd45a works, we hope to understand how muscle wasting occurs and to identify new ways to treat patients.